Epigenetic Determinants Influencing Development and Evolution of Chronic Post-surgical Pain in Children Undergoing Musculoskeletal Surgery.

PROJECT SUMMARY
Spine fusion and pectus repair are among the most painful musculoskeletal surgeries adolescents undergo, with
a high incidence of chronic postsurgical pain (CPSP). CPSP is detrimental to recovery and increases the risk for
disability as well as prescription opioid abuse. Understanding CPSP risk is important for development of effective
preventive and therapeutic strategies. Although genetic, psychosocial and environmental factors explain some
of the variance in CPSP risk, there remain critical gaps in CPSP risk prediction and understanding of longitudinal
gene-environmental influences on long-term pain responses after surgery. This leads us to our global
hypothesis that epigenetic processes will influence the development and evolution of CPSP. DNA methylation
(DNAm) is a key epigenetic mechanism known to influence transcription and transition of acute to chronic pain.
Preliminary data: Our pilot epigenome-wide association study (EWAS) in spine surgical subjects showed that
CPSP is associated with differential DNAm in 39 genes which enrich GABA, Dopamine-DARPP32 Feedback in
cAMP and immune signaling pathways. Our previous findings that DNAm of Mu opioid receptor gene promoter,
perioperative pain and opioid exposures predict CPSP, lead us to believe that DNAm mediates the association
of perioperative stressors with long-term pain phenotypes. Increased cytokine levels and DNAm-expression
correlations in CPSP (pilot data) suggest differential epigenetic regulation influencing immune cell-specific gene
expression in CPSP. Scientific objectives are to determine blood DNAm biomarkers for CPSP and evaluate
temporal origins of CPSP-associated epigenetic variation in relation to pain-opioid exposures and inflammatory
responses. The premise for the potential utility of blood based DNAm as CPSP biomarkers is supported by
cross tissue comparison studies of brain-blood DNAm correlations and blood DNAm signatures reported for
several neural phenotypes. Aim 1: Determine and validate differentially methylated regions predictive of CPSP.
The working hypothesis is that CPSP will be significantly associated with DNAm markers in preoperative blood
samples after adjusting for demographic, psychosocial and perioperative factors. We will conduct a prospective,
multisite EWAS for discovery-validation (N=1165 opioid-naïve children undergoing spine fusion) and replication
of candidate markers (N=300 children undergoing pectus repair). Since cross-sectional epigenetic studies are
potentially affected by reverse causation bias and genetic variation confounders, we propose novel longitudinal
studies to evaluate perioperative stress related DNAm changes. Aim 2: Determine longitudinal changes in
DNAm profiles associated with pain and opioid exposures and explore their role in mediating associations with
CPSP. Aim 3: Characterize cytokine profiles, immune cell subsets and epigenetic regulation of immune cell
specific gene expression in CPSP. It is anticipated that this study will identify novel epigenetic biomarkers for
CPSP, provide novel insights into longitudinal epigenetic mechanisms in the evolution of CPSP, and uncover
promising therapeutic targets for CPSP, with extended implications for other chronic pain conditions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it advances the understanding of gene- environmental influences on the transition from acute to chronic pain after surgery in children, and fosters development of individualized, targeted, approaches to prevent and treat long-standing pain. Thus, it is especially relevant to the part of NIH’s mission that supports patient-oriented research for application of personalized medicine to improve quality of life, decrease functional disability, and decrease risk for opioid abuse, through effective pain management.